Scientific Transparency

Scientific Transparency: Project Summary
We introduce in this competing renewal the Scientific Transparency Core Module (STCM). This module places
the activities of the prior Image Analysis Core Module within a next-generation data curation framework, to
bring reproducible and shareable data analysis to VRC investigators. The STCM supports scientific rigor and
reproducibility in image analysis for VRC investigators, and provides support from the inception of an
innovative analysis approach, to its realization in code, to its application within a reproducible pipeline. Module
personnel support the development of innovative analysis tools. This core element of support continues from
the Image Analysis Core Module, which has been heavily used during the current funding cycle. We aim to
create automated, open-source analysis algorithms that provide reproducible results. Module personnel will
also support data curation and analysis pipelines. This module function is based around the commercial
Flywheel platform (http://flywheel.io). Brain imaging data obtained by Participating Investigators are already
being stored on this system; the STCM will underwrite the costs of placing retinal imaging data on this platform.
Module personnel will further assist investigators in placing analysis code within analysis “gears” that operate
on data stored in Flywheel. These are software containers that allow open-source analysis code to be
executed, without external dependencies, on virtually any computer hardware or operating system. These
components create documented, reproducible analysis pipelines that may be shared between VRC
investigators and with the larger vision science community.